Modulating Pain Generators of Chronic Trigeminal Neuropathic Pain

Veterans have more severe chronic pain than non-veteran patients and are reportedly twice as likely to die of
an opioid overdose in attempts to find relief. These consequences lie behind the critical need to determine brain
alterations causing chronification of pain that are too often progressing to the anxiety and depression responsible
for the increased suicide rate among our veterans. Better understanding of underlying mechanisms driving
chronic pain is imperative to development of more effective non-opioid treatment approaches for chronic pain.
During the currently funded VA Merit grant period, we performed manganese enhanced MRI (MEMRI) studies
using our experimental chronic neuropathic pain model. MEMRI allows visualization of neural activation in the
small rodent brain using a 7T Bruker MRI scanner. As in clinical fMRI studies, we identified specific limbic
emotional brain regions overactivated by chronic pain in addition to activation of the pain circuitry itself. It is
apparent in our Preliminary Data histological follow-up that ongoing cellular stress is occurring in limbic brain
circuitry. Due to the neuronal overactivation, pathophysiological alterations in limbic brain pain circuitry include
increased expression of cellular stress biomarkers and altered expression of protective autophagy biomarkers.
Autophagy is defined as the ongoing cellular protective mechanisms removing damaged and misfolded proteins
generated during cellular stress. Disrupted autophagy homeostasis that produces autophagic dysfunction
adversely affects cell function and eventually viability. The goal of the proposed studies is to examine whether
boosting cell protective autophagy mechanisms can not only reduce neuropathic pain chronification related
behaviors but can conceivably reduce the related brain pain circuitry neuropathology. Our studies performed at
8-10 weeks after induction in our chronic neuropathic pain model allows salient clinical relevance.
We will test whether cellular stress/autophagy mechanisms are related to the noradrenergic alpha 1 receptor
(NAα1R) signaling we identified as a primary chronic pain generator in the previous Merit grant funding period.
The NAα1R blocker we will test is the clinical therapeutic doxazosin that might also be used as PTSD therapy.
Doxazosin is longer lasting than the prazosin we tested in the same model in the previous grant period. Prazosin
reduced chronic pain and aversive anxiety and depression related behaviors we observed through the 10 week
time points (see Progress Report). We will test efficacy of doxazosin to reduce chronic neuropathic pain induced
mechanical hypersensitivity, and perform anxiety and depression related behavioral assays. Comparisons of the
efficacy of doxazosin can be made to prazosin and the effects of cellular stress inhibitors/autophagy enhancers.
We find based on our recently completed MEMRI study that overactivation in specific limbic cortical regions after
10 weeks of ongoing neuropathic pain results in altered cellular stress/autophagy biomarker expression that
accompanies the chronic pain related behaviors. The Aims proposed in this VA Merit renewal application include
identification/validation of the cellular stress/autophagy RNA/protein expression signature in the chronic pain
model at 10 weeks. Pilot efficacy testing of a cellular stress signaling pathway inhibitor and protective autophagy
promotor finds reversal of chronic pain behaviors. Enhancement of protective autophagy mechanisms as
defense against cellular stress and disrupted cellular homeostasis will be further demonstrated by quantifying
oxidative stress/autophagy RNA, proteins, and other neuropathology as readouts. Imaging the distribution of
inflammatory biomarker cathepsin B over time in live animals with whole body IVIS fluorescent infrared imaging
will be a readout of the inflammatory component in peripheral and central nervous system.
Completion of our assessment of the efficacy of these treatments to provide enhancement of protective
autophagy mechanisms during chronic pain as defense against cellular stress and chronic pain related behaviors
will increase the understanding of the chronification of neuropathic pain. Improved understanding will lead to
better non-opioid treatments for chronic pain that provide better outcomes for veterans living with chronic pain.

Public health relevance
NARRATIVE The overall goal of the proposed Merit renewal studies is to improve management of chronic nerve injury pain suffered by many veterans after blast, vehicular accident, and other combat injuries. Chronic head and neck pain are chief complaints of approximately 772,000 of the 2.5 million military personnel deployed since 2001 seeking care in the VA health care system. A clinically relevant experimental model of chronic pain is used to provide information not attainable with acute models including anxiety and depression measures that can accompany chronic pain. The central pain generator identified in the previous grant period driving intense activation of the nervous system during chronic pain also drives the appearance of cellular oxidative stress and damage proteins. This indicates restorative processes that protect cellular function are compromised in the pain processing circuitry. Proposed studies will test efficacy of oxidative stress inhibitors and enhancement of cellular protection mechanisms as means to limit effects of chronic pain.